Promoting PrEP shared decision-making and adherence among pregnant and breastfeeding women in Zambia

ABSTRACT
Pre-exposure prophylaxis (PrEP) is a promising tool for the prevention of HIV acquisition during pregnancy and
the postpartum period and is a recommended component of a comprehensive package of prevention of mother-
to-child HIV transmission services. Yet, few strategies exist to promote person-centered shared decision-making
about PrEP use during pregnancy and breastfeeding despite the complexity of this decision and the importance
of shared decision-making for medication adherence. The proposed training and research plan in this Mentored
Research Scientist Development Award (K01) application will provide the essential training and skills that the
principle investigator, Dr. Lauren M. Hill, PhD, needs to launch a productive career in PrEP decision-making
research and in the development and evaluation of behavioral interventions to promote the utilization of and
adherence to medicines for the prevention and treatment of HIV. Further, the research conducted throughout
the course of this award would contribute meaningfully to the successful delivery of PrEP in the context of
antenatal care in sub-Saharan Africa to ensure that decision-making regarding PrEP use by pregnant and
breastfeeding women is person-centered to encourage appropriate and adherent use. To achieve this, Dr. Hill
proposes three aims: First, she will identify values important to women’s decision-making about PrEP use during
pregnancy and breastfeeding through a mixed methods formative study. Second, using this information and the
results of a comprehensive needs assessment with pregnant women, their partners, and antenatal health care
workers, she will develop a PrEP shared decision-making aid. Third, she will conduct a pilot trial to evaluate the
effect of the shared decision-making intervention on the proximal cognitive endpoint of decisional conflict and
explore the treatment effect on PrEP adherence. The training acquired by Dr. Hill through this timely study, in
combination with didactic coursework, applied training, and mentorship will target the four training objectives: 1)
to build expertise in medical decision-making with a focus on the development and evaluation of shared decision-
making interventions; 2) to gain training in methods for the design, management, and analysis of trials to evaluate
clinical interventions supporting the use of biomedical HIV prevention methods; 3) to master skills in the design
of mixed methods studies and integration of mixed methods data for intervention design and evaluation; and 4)
to develop the professional skills, expertise, and pilot data to facilitate her development toward research
independence. Dr. Hill proposes to achieve these goals through a rigorous program of training and research to
build upon and complement her training and experience in behavioral research for the primary prevention of HIV
to fully prepare her for a career as an independent scientist in the field of global HIV/AIDS prevention.

Public health relevance
PROJECT NARRATIVE Pre-Exposure prophylaxis (PrEP) represents an opportunity to dramatically reduce the elevated risk of HIV in pregnant and breastfeeding women in sub-Saharan Africa, but shared decision-making about its use is essential to identify appropriate users and promote adherent use. The proposed study aims to develop and pilot test a PrEP shared decision-making aid for pregnant women in Zambia to determine if use of the aid effectively promotes personally appropriate decisions about PrEP use, and to understand if and how its use may serve to promote adherence among PrEP adopters. This aid will be designed according to the relevant values and decision-making needs of pregnant women, their male partners, and antenatal health care workers.